Integrating PrEP Decision-Making into Contraceptive Counseling in Family Planning Clinics

Problem: There is high unmet need for PrEP among cis-gender women in the U.S. Even where
resources are available to support PrEP, it remains inaccessible to women because too few
clinical settings provide it. Purpose: To support women’s choice, we will expand and enhance a
PrEP decision aid to include the full array of available formulation options and then integrate its
delivery into sexual and reproductive health (SRH) settings during contraceptive counseling
visits, where PrEP can be provided to all women who are interested. Methods: Project
Carmenta is guided by the Health Equity Implementation Framework, critical ongoing input from
our Community Advisory Board and the cumulative expertise of the study team in HIV
prevention, sexual and reproductive health, decision science, implementation science, and
family planning epidemiology. We will engage patients (n=15-20), clinicians (n=10), and staff
(n=10) at SRH clinics across Greater New Haven, CT for semi-structured interviews to expand
and enhance an existing PrEP decision aid to include all available formulations and optimize its
integration into SRH clinics. Qualitative interviews will inform infrastructure development to
support PrEP delivery in SRH clinics. In a hybrid Type 2 effectiveness-implementation study, we
will then randomize patients (n=50) to receive either the PrEP decision aid or generic PrEP
information prior to a clinician visit. In follow-up interviews immediately post-visit, and at Months
3 and 6, primary outcomes are clinical efficacy (PrEP initiation) and implementation (using
Proctor definitions for feasibility, acceptability, penetration, and adoption) that are important for
future planned scale-up. Aims: The Aims of the project are: 1) To expand and enhance an
existing decision aid on PrEP, and assess innovation, clinical encounter, recipients, and context-
level factors affecting its integration into contraceptive counseling visits in SRH clinics; and 2) To
integrate the expanded patient-facing individual PrEP decision aid into contraceptive counseling
visits and evaluate clinical and implementation outcomes. Significance: The proposed research
directly addresses the key objectives of RFA-MH-24-332 and priorities of the NIH Office of AIDS
Research by using a decision aid to support women’s choice of PrEP product and providing new
insights on how women weigh each option. Significance is high because integration of PrEP into
SRH reduces barriers to access for women. Innovation is high because of the use of a gender-
and trauma-responsive PrEP decision aid for women within a SRH setting. Public health impact
is high because of a focus on achieving health equity in a rapidly changing SRH landscape and
supporting women’s choice of PrEP.

Public health relevance
Narrative There is high unmet need for PrEP among cis-gender women in the U.S. and, even where PrEP is available, it is often inaccessible to women because too few clinical settings provide it. We address this important adoption gap by integrating PrEP decision-making and delivery into contraceptive counseling in sexual and reproductive health clinic settings, which supports women’s choice. Guided by the Health Equity Implementation Framework and sustained input from a Community Advisory Board, we will randomize patients in these settings to receive an expanded PrEP decision aid vs. generic PrEP information, evaluating clinical and implementation outcomes important for understanding scalability and sustainability.